Sharpey's fibers and PDL regeneration

Periodontitis is one of the most prevalent diseases. In the United States, 42% of adults are affected by
periodontitis, with 7.8% having severe cases. Destructive periodontitis is characterized by irreversible loss of
periodontal tissues, including periodontal ligament (PDL) and alveolar bone. While many efforts have been made
to develop tissue engineering-based approaches to reconstructing the structures and functions of the
lost/damaged periodontal tissues, none of those approaches can achieve predictable and long-term functional
periodontal tissue regeneration. One of the major obstacles is the difficulty in regenerating well-organized
Sharpey’s fibers that are the terminal ends of PDL principal fibers and are embedded in alveolar bone and
cementum. Without these highly oriented Sharpey’s fibers, there would be no functional connection between
PDL and alveolar bone/cementum; and the integrity of the periodontal tissues would be impaired, leading to
tooth loss. To date, there is no effective bioengineering approach to regenerating PDL Sharpey’s fibers. The
overall objective of this proposal is to develop a bio-inspired scaffold (periopatch) for Sharpey’s fiber and
periodontal tissue regeneration. The hypothesis is that integration of crucial biophysical and biochemical cues
into a bio-inspired matrix will provide a suitable microenvironment to guide periodontal ligament stem cells
(PDLSCs) migration, growth, and form well-aligned PDL principal and Sharpey’s fibers. In the preliminary study,
tubular architecture of the matrix and tenascin-c (a PDL glycoprotein) were identified as the pivotal biophysical
and biochemical factors, respectively, to regulate PDLSC migration and form PDL principal fibers. A unique
pyrophosphate/alkaline phosphatase (PPi/ALPase) system in the tubular matrix were further developed to
precisely control mineral deposition at the PDL/bone interface to guide Sharpey’s fiber formation. In addition, a
bioengineering technology was developed to integrate these crucial elements into a bio-inspired triphasic
scaffold for functional Sharpey’s fibers and periodontal tissue regeneration. Based on these exciting preliminary
data, three aims are proposed in this proposal. Aim 1 will focus on developing and optimizing a bio-inspired
tubular matrix to guide PDL principal fiber formation. Aim 2 is to rebuild the microenvironment for Sharpey’s fiber
formation. Aim 3 will focus on regenerating Sharpey’s fibers and periodontal tissues using a periodontal
fenestration defect model. Successful completion of this project will address one of the major challenges in
periodontal regeneration, making a significant step toward regenerative periodontal therapy in clinic settings.

Public health relevance
Project Narrative This proposal aims to regenerate Sharpey’s fibers and periodontal tissues that are lost due to periodontitis. Completion of this project will develop an innovative bioengineering approach to regenerate predictable and functional periodontal tissues, therefore, improve the health of hundreds of millions of people in the U.S.